Minimally invasive quantitative tissue oxygen sensors to personalize cancer care

Project Summary and Abstract
Hypoxic (oxygen depleted) tumors are more resistant to treatments including radiation therapy. This trend has
been seen across a wide range of cancers including prostate, head and neck, and cervical. Radiobiological
studies have shown that elevated radiation doses can be used to overcome hypoxia-induced resistance and
achieve the same level of effectiveness as lower doses in more well-oxygenated environments. The major
impediment to implementing this (and other) hypoxia targeting therapies is the lack of a suitable oxygen sensor.
Actionable oxygen sensors should be quantitative, workflow compatible, and provide spatial context for each
measurement. Current and past alternatives for oxygen sensing are either qualitative, too invasive, or both. The
proposed oxygen sensor will offer a workflow-compatible method to obtain quantitative tumor oxygen data. The
sensor is measured non-invasively using MRI which provides a spatial/anatomical context for each
measurement. The sensor is made completely of silicone, inserted with minimally invasive methods, equilibrates
quickly with the surrounding tissue, and is fully reversible. The polymeric nature of the material allows it to remain
at the site of insertion indefinitely to enable long-term monitoring. The proposed work focuses on selection of a
lead formulation (Aim 1), evaluation in a small animal tumor model (Aim 2), and evaluation in a large animal
model to mimic the tissue volumes expected during human use (Aim 3). The sensor produced as part of this
proposal will be translatable to additional applications in oncology, but also to non-oncology applications
including tissue health and trauma.

Public health relevance
Project Narrative Low oxygen tumors are more resistant to treatment and lead to poorer outcomes for patients. Boosting radiation dose to the low oxygen regions of the tumor offers an opportunity to overcome this resistance, but has been limited due to the lack of a suitable clinical oxygen sensor. The proposed oxygen sensor would overcome the limitations of existing alternatives and offer the opportunity for personalized treatment approaches.